Contributing Factors and Consequences of Cancer Health Disparities

PROJECT SUMMARY / ABSTRACT
Disparities in the incidence and prognosis of cancer in the United States are widespread, well documented,
and persistent. Still, there remains a critical need to thoughtfully examine and address the myriad factors
contributing to these disparities. For the past 20 years, we have conducted a Training Program in cancer
prevention and survival (15 years as an R25, 5 years as a T32), with an emphasis on the roles of nutrition,
lifestyle factors, and genetics in cancer. We have had substantial success in trainee degree completion,
recruitment of trainees from underrepresented backgrounds, and placement of pre- and postdoctoral fellows in
research-related positions. With this renewal, we are proposing to reframe the focus of our Program to support
trainees in the pursuit of research on cancer health disparities and the social determinants of health that drive
those disparities. The objective of this Program is to advance opportunities for trainees, particularly those from
underrepresented backgrounds, in research for the reduction and elimination of cancer health disparities. In
pursuit of this objective, we will provide trainees with 1) formal coursework in cancer epidemiology, social
determinants of health, and cancer disparities, 2) experiences in epidemiologic research, with an emphasis on
cancer epidemiology and health disparities research, and 3) skills and practice in grant writing, disseminating
scientific findings, and developing a long-term career plan. Together, these activities will support our trainees in
preparing them for careers in impactful research. We propose to train 4 pre- and 3 postdoctoral trainees each
year. Formal coursework and degrees will be based in the University of Washington (UW) Department of
Epidemiology. Trainees will gain practical experience in epidemiologic research within the UW Department of
Epidemiology and at the Fred Hutchinson Cancer Center. Trainees will have access to considerable resources
and 26 exceptional faculty mentors at these two partner institutions. New faculty mentors have been added to
provide expertise in health disparities and social determinants of health, along with several junior faculty co-
mentors with innovative research directly relevant to the goals of this Training Program. This Training Program
will be led by two Program Directors, both of whom hold joint appointments at the two participating institutions
and share a history of collaborative research in studies of cancer disparities: Dr. Amanda Phipps is an
Associate Professor and Associate Chair at the UW Department of Epidemiology; Dr. Christopher Li is a
Professor, the Vice President for Faculty Affairs and Inclusion, and Associate Director of the Office of Diversity,
Equity, and Inclusion at the Fred Hutchinson Cancer Center. Through the support of Drs. Phipps and Li, the
oversight of knowledgeable internal and external advisors, and the guidance of outstanding Program faculty
mentors, trainees who complete this Training Program will have the knowledge and skills to conduct impactful
independent research addressing the root causes and consequences of cancer health disparities.

Public health relevance
PROJECT NARRATIVE / RELEVANCE This overall goal of this Training Program is to provide critical support and training to prepare the next generation of cancer prevention researchers, committed to reducing the burden of cancer by addressing factors that contribute to cancer health disparities. The training focuses on cancer epidemiology and social determinants of health in relation to health disparities through didactic instruction, career development support, and the conduct of high-quality research with a skilled team of mentors.